Infections and the Risk of Parkinson's Disease

PROJECT SUMMARY
Parkinson’s disease (PD) is an incapacitating neurological disorder for which there is no effective treatment that
can halt or reverse the progression. The lack of effective treatments is due in part to the poor understanding of
the causes of this condition. Interestingly, it has been proposed that infections may play a role in causing PD.
This hypothesis is supported by the fact that infections can cause other neurological diseases, such as multiple
sclerosis, and by evidence from some scientific studies suggesting a potential link between specific microbes,
such as Influenza viruses, and PD. Although some of the evidence is tantalizing, scientific studies have not
generated consistent results, and had important limitations in their design (e.g., lack of information on factors
that may alternatively explain a link between infections and PD). We propose to address these limitations by
conducting a comprehensive investigation into the role of infections in the development of PD and non-motor PD
signs and symptoms (e.g., constipation, smell loss) that often appear before the disease is clinically diagnosed.
The study will take advantage of data and blood samples that have been prospectively collected from thousands
of individuals who participate in two large studies: the Nurses’ Health Study, and the Health Professionals Follow-
up Study. These individuals have been followed for several decades, and we have identified those who
developed PD during this time. Our study population will comprise a subset of 120 individuals who developed
PD and whose blood sample was taken before PD diagnosis and a similar group of 120 individuals who did not
develop PD during follow-up. We will use a state-of-the-art laboratory method to measure the immune response
to over 1800 proteins mapping to 160 virus and bacteria. The proposed project stands to produce groundbreaking
results on the potential role of viral and bacterial infections in PD etiology, setting the stage for larger and more
comprehensive epidemiological investigations. Most importantly, the information generated by the proposed
project could lead to the development of novel treatments for PD.

Public health relevance
PROJECT NARRATIVE We propose to investigate the impact of infections from a wide range of viruses and bacteria on the future development of Parkinson’s disease (PD) and non-motor features (e.g., constipation, smell loss) that often appear years before the disease can be diagnosed. This project will provide new insights into the potential infectious causes of PD, setting the stage for larger and more comprehensive investigations, and ultimately leading to the development of effective treatments.